Virtual Reality Technologies for Dynamic Balance Rehabilitation in People with Stroke

PROJECT SUMMARY/ABSTRACT
This project aims to quantify and establish elements of immersive virtual reality (VR) software that, when
paired with treadmill training, produce balance perturbations that can be scaled to improve dynamic balance
and are tolerated by people with stroke. VR continues to be used as an interactive and engaging way for
clinicians to interact with patients during physical therapy, increasing effort given by patients and reducing
costs of equipment. There lacks, however, a proven immersive VR system that works for dynamic balance
rehabilitation protocols for neurological patients, such as those with stroke, to improve balance during walking.
Improvements in dynamic balance would lead to a decreased risk of falls, increased mobility, and would
ultimately improve quality of life for patients. In addition, a VR system that can be used on a treadmill to train
balance would fill an unmet clinical need for task-specific therapeutic interventions to reduce the risk of falls in
people with stroke. Kobuk Technologies has developed an alpha version of such a system and will work
together with Dr. Schmit at Marquette University to advance development of the system so that it can be tested
in people with stroke. A feasibility study will then be conducted in people with stroke to ascertain how the
system challenges balance by encouraging users to reach for targets in the VR environment while stepping on
a treadmill. Information from this study will then be used to build a beta version of the VR system for efficacy
testing. Aim I of the proposed research in this STTR Phase I will focus on quantifying balance responses to
reaching in an immersive VR environment on a treadmill, as these data are required scaling difficulty of the VR
reaching tasks. Aim II will characterize the coupling of treadmill speed and reach in a VR environment since
individual walking speeds for such a system will be necessary. Aim III will determine the length of time that
people with stroke tolerate an immersive VR environment during treadmill stepping. This research is critical to
the development of a VR treadmill training system for the rehabilitation of balance. The project will yield a VR
system that can then be used in an STTR Phase II efficacy trial to demonstrate improvements in gait function
in neurologic patients. Ultimately, Kobuk Technologies will create a new low cost tool for clinicians to use with
their patients during treadmill training that will substantially enhance the effectiveness of gait rehabilitation.

Public health relevance
PROJECT NARRATIVE This project aims to test the feasibility of an immersive virtual reality (VR) system for dynamic balance rehabilitation. The knowledge generated through this work will ultimately lead to a clinical system that can be used for balance recovery in patients with neurological disorders, such as stroke. The VR system developed through this process will be inexpensive, easy-to-use, and engaging and it will increase mobility, reduce the risk of falls, and lead to an improved quality of life.